Method development for simultaneous automatic assignment and structure determination in protein NMR

Protein NMR is a powerful tool for studying protein structure, dynamics and interactions at
atomic resolution. However, currently it is time-consuming and laborious to obtain NMR
resonance assignment and the NMR structure of a protein. Here we will leverage recent
advances in Euclidean distance geometry to develop a method for simultaneous
determination of resonance assignment and protein structure using only the NOESY spectra.
We have two aims: 1. Method development and validation using synthetic data based on
known protein structure; 2 Method development and validation using experimental NMR
data.

Public health relevance
Current NMR methods for resonance assignment and structure determination are laborious, time-consuming and expensive. Here we will develop a new method to accomplish assignment and structure determination using only NOESY data, based on recent advances in Euclidean distance geometry. Such a new method will have extensive applications in protein science and in drug discovery.